Decision making in the context of multi-attribute options

Project Summary
There is often not an obvious best choice when making a decision, particularly when deciding between
options that have multiple features, or attributes. For example, when deciding between lunch options, one
might factor the taste, price, and nutritional quality of an option into one's selection. Additionally, such
choices may also be inﬂuenced by other processes, such as the choice context or one's attention. The
orbitofrontal cortex (OFC) plays an important role in representing associations between stimuli and values,
and has been suggested to represent the overall value of an option integrated across its attributes. However,
it remains unknown whether options are necessarily evaluated only on the basis of an integrated value, as
suboptimal decision-making eﬀects like the attraction eﬀect point to the possibility of within-attribute
comparison. Furthermore, choice behavior is known to interact with visual attention to produce choice biases,
indicating a role for the frontal eye ﬁelds (FEF), an area linked to visual attention and also known to respond to
the value of visual targets. In order to investigate how multi-attribute choices are instantiated in neural activity,
we will train two rhesus macaques on a multi-attribute decision making task, in which each of two
simultaneously-presented options consists of two attributes: the sweetness of that option's sucrose reward,
and the probability that the animal will receive that reward. The information about each attribute is
represented by separate bars that either increase or decrease with increasing attribute value, a relationship
that was denoted by the color of the bar. This allows us to investigate both free-viewing gaze behavior and
changes in choice behavior due to diﬀerences in attribute value as well as visual presentation. Our preliminary
data show that when the stimuli of shared attributes matched each other across option (e.g., both reward
bars increased in size with increasing sweetness), choice behavior improved from baseline, while when the
stimuli of shared attributes did not match each other across option (e.g., reward bar A increased in size with
increasing sweetness, while reward bar B decreased), choice of the better option became suboptimal,
implying a role for within-attribute comparison in the choice process. This proposal combines robust
behavioral techniques with high channel-count multi-unit recording in OFC and FEF to investigate how multi-
attribute options are compared and how attention is involved in complex decisions. We hypothesize that
correlates of attribute value and comparison will be present in the OFC, and that functional connectivity
between OFC and FEF will depend on the focus of visual attention during choice and valuation. Our ultimate
goal is to further elucidate the neural mechanisms of complex decision-making to better guide the
development of treatments for neuropsychiatric conditions in which it is impaired.

Public health relevance
Project narrative Neural correlates of economic value have been established in the primate orbitofrontal cortex; however, further evidence suggests that when engaging in complex decisions between options with multiple attributes, choices may be partially made on the basis of interactions between attributes, rather than direct comparison between integrated economic values. These processes have also been suggested to be inﬂuenced by visual attention. This project aims to uncover the neural correlates of option attributes in multi-attribute value-based choice, and suggest potential mechanisms by which value-based choice is computed and inﬂuenced with respect to context and attention.